Early Periodontal Health Impacts of Electronic Nicotine Delivery System (ENDS) Usage

Project Summary
The use of electronic nicotine delivery systems (ENDS) increases the risk of a number of diseases including
those of the oral cavity. Specifically, of concern is the induction of gingival inflammation and increased
susceptibility to bacterial invasion, ultimately leading to the development of periodontal disease (PD). How and
why ENDS use may pose PD risk is unclear as there is a lack of comprehensive data on usage behaviors,
exposures, and disease outcomes. Further, there is a lack of early indicators of PD associated with ENDS usage,
which impedes initial diagnosis and the development of disease prevention strategies. We hypothesize early
indicators of adverse ENDS-related oral health outcomes can be identified and explained by variations in ENDS
preference/usage and biological responses. To address this hypothesis, we will establish a behavior-exposure-
toxicity-disease paradigm utilizing aims specifically designed to evaluate ENDS usage and clinical manifestations
of oral disease (Aim 1), common ENDS products and molecular mechanisms of disease (Aim 2), and translatable
indicators of disease susceptibility (Aim 3). This innovative approach will facilitate our knowledge regarding the
mechanisms and biomarkers of ENDS-mediated oral health effects that can be directly applied to disease
prevention strategies. In Aim 1, we will recruit cohorts of never-established tobacco users and current exclusive
ENDS users to evaluate ENDS usage behaviors, oral health, and risk factors. In this aim, we will employ an
established social media recruitment strategy to recruit participants and evaluate participant characteristics,
ENDS usage, and oral health history via focused questionnaires. Additionally, ENDS usage will be examined
through real-time monitoring of ENDS puffing topography. Clinical manifestations of disease will be assessed by
an oral health exam and examination of the subgingival microbiome. To elucidate the role of product-based
ENDS exposures we will utilize an in vitro air liquid interface model system to expose primary gingival
keratinocyte/macrophage spheroids to aerosols in Aim 2. These exposure scenarios will utilize established
protocols for comparative toxicity assessments while also incorporating exposures representative of ENDS
usage from our recruited participants. Specifically, these in vitro experiments will assess brand-specific
modulation of inflammation, oxidative stress, DNA damage/repair, epithelial-mesenchymal transitions, and
bacterial invasion. In Aim 3, we will utilize a molecular epidemiology approach to assess the impact of ENDS
usage by the examination of participant saliva, gingival cells, and subgingival plaques. These represent readily
available matrices to examine early indicators of oral disease and PD initiation including biomarkers of
inflammation, oxidative stress, DNA damage/repair, epithelial-mesenchymal transitions, and microbial
alterations. Specifically, we aim to establish a pathway between participant characteristics, ENDS usage, and
toxicological mechanisms contributing to PD development that can be applied to protect public health.

Public health relevance
Project Narrative Electronic nicotine delivery systems (ENDS) aerosols contain a variety of hazardous components, which contribute to reduced oral health leading to periodontal disease progression. Identifying early mechanisms and biomarkers of harm and disease initiation due to ENDS use will require comprehensive appraisal of factors including usage behaviors, individual characteristics, clinical manifestations, and biological responses. We theorize that variances in ENDS usage modulates exposure inducing adverse cellular responses including gingival inflammation and enhanced susceptibility to bacterial invasion causing early onset of periodontal disease.